Assessing, Optimizing, and Delivering Surgical Feedback with AI for Benign Urological Robotic Surgeries

ABSTRACT
The feedback exchange between trainer and surgical trainee is critical for determining the rate of skill
acquisition and subsequently improving patient outcomes. However, such feedback is inconsistent during
formal surgical training and almost non-existent once training is complete, when surgeons may yet become
fully proficient. For complex robotic procedures, surgeons may expect learning curves of up to 100-400 cases
before achieving stable patient outcomes. Optimized surgical training, through real-time feedback measured
objectively for effectiveness, can shorten the path toward surgical proficiency and ultimately decrease patient
morbidity.
To address this need for consistent and effective feedback, we will assess the present exchange of surgical
dialogue throughout 500 benign urological training cases, recorded in the live operating room among five
nationally recognized medical centers (Aim 1). Benign urological surgeries serve as an ideal test case for
systematically categorizing and assessing live surgical feedback from a trainer to surgical trainee. Through the
development of robust statistical tools and performance of randomized control trials in our training lab, we will
investigate how to optimize human-delivered feedback (Aims 1-2). We will simultaneously harness artificial
intelligence (AI) to automatically identify the need for and deliver video-based surgical feedback to novice
surgeons in the lab (Aim 3), filling the observable gap during training and beyond.
PI Hung and his team have two active R01 grants based on developing AI tools to assess surgeon
performance, providing basic skills evaluation automatically and in near real-time. This proposal seeks to
discover how feedback can be delivered back to the surgical trainee. PI Hung has piloted a system to trigger
feedback in response to the assessment of low skill, in collaboration with AI scientist Co-I Huang and
psychologist Shtulman, demonstrating as well in their preliminary work that such feedback can meaningfully
improve surgical action.
We hypothesize that 1) human-delivered live surgical feedback can be optimized, and 2) AI-delivered
feedback is effective in improving surgical performance.
Despite its critical importance for surgical training, understanding and improving surgical feedback has
received little investment. Our work, if successful, will create a framework by which surgical educators’ live
instruction can be objectively assessed, allowing for downstream, data-driven optimization of surgical training.
Our AI-based automated feedback system will provide maturing surgeons access to consistent and effective
surgical feedback in the training lab, promising to reduce procedure learning curves and ultimately improve
patient outcomes.

Public health relevance
PROJECT NARRATIVE The proposed work seeks to quantify and improve the real-time feedback dialogue evaluated between trainer and surgical trainee in the live operating room. Benign urological robotic surgeries are an ideal test case for this study, requiring a broad range of surgical skills that will elicit diverse demonstrations of trainer feedback. The proposed work will also develop an artificial intelligence (AI)-based system to automatically deliver video feedback in response to poor surgical performance, bridging the transition between formal training and afterward when surgeons typically receive little to no routine feedback.